Long term efficacy and safety of orlistat for type 1 hyperlipoproteinemia: a randomized, double-blind, placebo-controlled trial

Abstract
Type I hyperlipoproteinemia (T1HLP, also known as familial chylomicronemia syndrome or FCS) is a rare,
autosomal recessive metabolic disorder characterized by extreme hypertriglyceridemia due to a deficiency of
lipoprotein lipase or related proteins. Treatment of these patients is challenging as conventional triglyceride-
lowering medications, such as fibrates and fish oil, are ineffective. An extremely low fat diet is helpful, however,
despite good dietary compliance, some patients continue to have severe hypertriglyceridemia and recurrent
pancreatitis which can be life threatening. There is a pressing need for developing novel therapeutic options for
these patients, as currently, there is no FDA approved medication. Our recent preliminary data from a
randomized, open-label, clinical trial of orlistat (an inhibitor of intestinal lipase) with a four-period, two- sequence
(“orlistat” and “off orlistat” for 3 months), crossover study design in two young males (11 and 9 years old) with
T1HLP revealed more than 50% reduction in fasting serum triglycerides with only minimal side effects. However,
the long-term efficacy and safety of orlistat therapy for children and adults with T1HLP remains unknown.
Potential complications of long-term orlistat use include deficiencies in fat soluble vitamins, steatorrhea,
hyperoxaluric nephrolithiasis, and alteration in fecal microbiota.
Therefore, we wish to study the long-term efficacy and safety of orlistat for reducing serum triglyceride levels in
patients with T1HLP. We plan to enroll 28 patients with T1HLP (fasting serum triglycerides ≥ 1,000 mg/dL) in a
randomized, double-blind, placebo-controlled, cross-over trial with an open-label extension. After a screening
evaluation, the subjects will be advised to consume an extremely low fat diet (≤15% of total energy from fat) for
the entire duration of the study. After the baseline period of 8 weeks, they will be randomly assigned to placebo
or orlistat for the duration of 24 weeks (Phase 1). After Phase 1, all patients will enter an open-label extension
(Phase 2) and receive orlistat for a period of 24 weeks for a total duration of 48 weeks. During the last week of
Baseline Period, Phase 1, and at 24 weeks of Phase 2, patients will be admitted to the in-patient Clinical
Research Unit for 4 days to measure serum lipoproteins and chemistry panel for 3 consecutive days, fat-soluble
vitamin levels, 24 hour urine oxalate and stone risk profile, mineral balance, 72 hour fecal fat, fecal microbiota,
hepatic triglyceride, liver and spleen volume, and will complete gastrointestinal and quality of life questionnaires.
The primary endpoint will be fasting serum triglycerides. The secondary endpoint variables will be apolipoprotein
B-48 levels, liver fat content and volume. Safety will be assessed by measuring fat soluble vitamins levels, body
weight, quality of life, gastrointestinal symptoms, oxalic aciduria, fecal fat excretion and fecal microbiota.
Generalized linear mixed models will be used for statistical comparisons. Our data will determine long-term
safety and efficacy of orlistat therapy for patients with T1HLP and orlistat may become the first line therapy as
an adjunct to extremely low fat diet in these patients.

Public health relevance
Narrative There are currently no FDA-approved therapies for Type I hyperlipoproteinemia, a rare, autosomal recessive metabolic disorder characterized by extreme hypertriglyceridemia due to a deficiency of lipoprotein lipase or related proteins. Our recent preliminary data in two children and an adult with T1HLP revealed 46-60% reduction in fasting serum triglycerides with Orlistat with only minimal side effects. Therefore, we wish to study the long-term efficacy and safety of orlistat for reducing serum triglyceride levels in patients with T1HLP in a randomized, double- blind, placebo-controlled, cross-over trial with an open-label extension.